Dengue Sequencing Project

To provide RNA from dengue viral isolates for sequencing at the NIAID funded Microbial Sequencing Center at The Broad Institute. The viral genomes will be sequenced as part of a project focused on the comparative genomics of dengue viruses to provide data sets to study viral evolution, pathogenesis, and to generate targets for new and improved drugs, vaccines and diagnostics.